Enhancing Student Diversity in Drug Addiction Research

PROJECT SUMMARY
The profound detrimental impact to society from individuals abusing drugs is well established. To meet the
challenge of developing new and effective treatments to help those that have succumbed to the temptation of
drug use and abuse, we need to inspire the next generation of students to pursue research careers in the field.
The need is particularly acute among populations of students who are currently underrepresented in the field of
drug abuse. Published analyses indicate that exposing undergraduate students, especially early in their career,
to laboratory research is an extremely effective way for developing their interest in research as a profession.
Since 1989, the University of Minnesota of has recognized and met this challenge by offering summer
residential research programs in the biomedical sciences. This proposal is the competitive renewal of a training
program that specifically provides research experience in the field of drug addiction. Our goal is to train
undergraduate students who have completed their freshman or sophomore years in college. We will recruit
students nationally, accepting students from groups that are underrepresented within the biomedical research
profession. We will provide them with a 10-week intensive research experience that will include professional
mentoring (academic survival skills and preparation for graduate school) as well as workshops on research
ethics. Our goal is to inspire a new generation of drug abuse researchers. In turn, we expect these individuals
to become part of the research infrastructure dedicated to solving medical problems of nervous system
dysfunction

Public health relevance
PROJECT NARRATIVE Drug abuse is an ongoing health concern. The goal of this competitive renewal is to continue support for a summer residential research program at the University of Minnesota with the hope of inspiring new generations of bright, talented undergraduate students, who are underrepresented in science, to pursue a career in the study of drug abuse. The hope is that these future scientists will contribute to the health infrastructure by discovering the mechanisms that underlie the neuroplasticity associated by the abuse of drugs, and to provide therapeutic measures to counteract these effects.